KAISER PERMANENTE OF NORTHERN CALIFORNIA (KPNC) ALCOHOL REGISTRY

This study will increase our understanding of the development of alcohol use disorders (AUD) and recovery from AUD, including factors that affect the likelihood of recovery success, such as quantity of alcohol consumed and the involvement of health and substance abuse comorbidities (NOT-AA-20-22) and treatment. The registry makes use of the annual Alcohol as a Vital Sign screening in primary care, and other health care data (e.g., demographics, comorbidities, pharmacy).